In-Clinic Latanoprost As a Novel Vaccine Adjuvant

In-Clinic Latanoprost As a Novel Vaccine Adjuvant
Abstract
Discovering in-clinic compounds with potent adjuvant properties for novel, effective and translational vaccines
is a high-priority research area. Through screening the NIH Clinical Collection, we have identified the in-clinic
drug Latanoprost triggering expression of proinflammatory mediators in skin, increasing skin-infiltration of
dendritic cell (DC) subsets, and enhancing induction of antigen-specific IFNγ+CD8 T cells and protective
immunity to the microneedle array cutaneous vaccination. In intradermal and intramuscular vaccinations,
Latanoprost promotes antigen-specific antibodies (Ab), including the effective anti-pathogen IgG subclass. We
hypothesize that Latanoprost functions as a novel T cell- and Ab-promoting adjuvant to enhance vaccine
efficacy with two aims: 1) determine Latanoprost’s vaccine adjuvant effects via DC subsets, 2) evaluate
Latanoprost’s adjuvant effects to skin and intramuscular vaccinations. If successful, our discovery of
Latanoprost as a new, safe, and effective T cell- and Ab-promoting adjuvant to skin and intramuscular
vaccinations would have a clinical significance on repurposing this in-clinic drug in immunizations.

Public health relevance
Narrative Our discovery of Latanoprost as a new, safe, and effective T cell- and antibody-promoting adjuvant to skin and intramuscular vaccinations would have a clinical significance on repurposing this in-clinic ready-to-use drug in immunizations.